Sleep Treatment Education Program-1 (STEP-1): A Randomized Trial of a Self-Management Insomnia Intervention for Cancer Survivors

Project Summary
Insomnia is one of the most common problems associated with cancer therapy; as many as 1 in 4 long-term
survivors report chronic insomnia even years after therapy completion.1, 2 As untreated insomnia is associated
with an extensive list of health problems (e.g., heart disease, hypertension, diabetes),3-12 the NCI emphasizes
the importance of addressing sleep in survivors,13 yet insomnia remains “under-recognized and undertreated”14
in survivorship care. Cognitive-behavioral therapy for insomnia (CBTI) is a well-established and empirically
supported treatment for insomnia. Multiple randomized trials have demonstrated its effectiveness in the
general population and in cancer survivors,15-22 and professional guidelines endorse CBTI as “front-line”
insomnia treatment.23 Yet, despite compelling evidence, CBTI is largely unavailable to the growing population
of cancer survivors who need it.24 Barriers to delivering CBTI to survivors include the significant burdens of
conventional CBTI leading to low adherence, and limited access. 25, 26 To address these challenges and deliver
effective insomnia treatment to cancer survivors, we developed the Sleep Treatment Education Program-1
(STEP-1), by refining brief insomnia interventions found successful in an NIH-funded trial (R03CA201459).
STEP-1 is a self-management CBTI intervention delivered as a single online educational session. Delivered in
a 75-minute, 1 on 1 session by an instructor, STEP-1 educates survivors about causes of insomnia after
cancer and introduces them to CBTI principles and methods. Using a symptom self-management approach,
STEP-1 supports survivors in implementing program recommendations into their daily lives with guided
behavioral planning and take-home materials. STEP-1 represents a significant innovation in CBTI treatment
and addresses barriers to treatment for cancer survivors because it is brief, low cost, and less burdensome
than currently available CBTI treatments. Based on single-arm trial results showing STEP-1 significantly
reduces survivors' insomnia, we propose a randomized controlled trial (RCT) of 70 cancer survivors evaluating
efficacy of STEP-1 to improve insomnia compared to an enhanced usual care control condition. Consenting
survivors ≥ 6 months off-therapy will be scheduled for an individual videoconference session in which they will
complete baseline measures using the Qualtrics web-based platform27 before being randomized (1:1) and
receiving their assigned intervention via live videoconference. At 4- & 8-weeks post-intervention, participants
will enter follow-up data directly into Qualtrics, with study staff assistance as needed, and receive a $25 gift
card for each follow-up assessment. We hypothesize insomnia symptoms (primary outcome) and mood
(secondary outcome) will improve significantly in STEP-1 participants relative to control participants (primary
aim). Secondary aims include identifying participant and intervention factors associated with clinically
significant response to STEP-1, evaluating acceptability of the control intervention, and exploring feasibility of
providing individualized coaching for participants without a significant response to the STEP-1 intervention.

Public health relevance
Project Narrative Despite overwhelming evidence supporting behavioral treatment for insomnia, it remains unavailable to millions of cancer survivors whose chronic insomnia goes untreated. To address this need, we propose to test STEP-1, an online educational intervention delivered by a trained presenter. By reducing the barriers to evidence-based treatment, STEP-1 has the potential to make effective insomnia treatment widely available for survivors, and to significantly improve their health and quality of life.